Capacity building in climate and health in the Peruvian Amazon

PROJECT SUMMARY
This D43 training grant is specifically designed to address and correct disparities in training opportunities for
researchers in infectious diseases between programs based in the capital in Lima and remote areas in Peru.
We offer a collaborative research training program in partnership with the Universidad Nacional de la Amazonia
Peruana (UNAP), the largest health education institution in the region. Peru is estimated to be highly impacted
by climate change, and the northern Amazon region is expected to experience extreme rainfall and flooding
events alternating with an extension of periods of low rainfall resulting in droughts. However, the effects of climate
change on health are complex and mediated by human adaptation and migration. To adequately forecast the
effects of climate change on the transmission and prevalence of infectious diseases these factors must be
understood at the local and regional level. This one year project will adapt and standardize a climate vulnerability
indices to Loreto and apply the index in a representative sampling across high flooding risk areas and study
human migration in Loreto. These activities will address key knowledge gaps that will enable reliable estimations
of the impact of climate change on endemic enteric and vector borne diseases. This information will be an
important baseline for the region to inform key stakeholders and provide them with standardized tools to measure
vulnerability. This in turn will allow for the programmatic assessment of future mitigation strategies and assess
changes in migratory patterns which are key determinants of endemic infectious diseases. The integrated
structure of planned research and training will engage UNAP faculty in best practice methodologies for climate
vulnerability research, enable the trainees to gain important practice in the conduct of representative sampling
for population-based research, and ultimately transition our trainees into roles consistent with their medium-term
career goals of becoming research faculty in UNAP. Doctoral students will be able to co-mentor other masters’
trainees through the integration of at least two additional trainees into the project. This intensive, mentored
training program will be led by faculty from our four collaborating institutions (UNAP, University of Virginia,
Universidad Peruana Cayetano Heredia [the leading biomedical research university in Peru], and Johns Hopkins
University). The integrated transdisciplinary team of enteric infectious disease epidemiologists, demographers,
earth and planetary scientists, data scientists, infectious disease modelers and local experts in tropical diseases
expect to build on the described research activities to pursue expanded opportunities in the study of climate and
health, specifically the effect of climate change on the epidemiology of enteric diseases, dengue, and malaria.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it will develop locally appropriate measures of vulnerability to climate change and measure human migration, two key factors that will effect our ability to understand and predict the impact of climate change on the transmission of enteric pathogens and vector borne diseases in a center of emerging infectious diseases research in the Peruvian Amazon. The transdisciplinary nature of this supplement will allow D43 trainees to have training input from additional faculty in earth and planetary sciences and the modelling of infectious diseases that will favorably impact their ability to conduct impactful research in climate change and public health in the future. Thus, the proposed research is highly relevant to the NIH’s strategic framework on climate change and health.